Imbalanced RF Receive Coil Array for Magnetic Resonance-guided Focused Ultrasound Neuromodulation

Project Summary/Abstract
Magnetic resonance-guided focused ultrasound (MRgFUS) neuromodulation is a groundbreaking, non-invasive
therapeutic technique that combines real-time magnetic resonance imaging (MRI) with the precision of focused
ultrasound (FUS). It offers a promising alternative to invasive brain stimulation methods for treating neurological
-time MRI guidance ensures
accurate targeting of brain regions, while MRI thermometry and Acoustic Radiation Force Imaging (ARFI) enable
safe monitoring, and functional MRI characterizes the spatial and temporal neural responses to FUS stimulation.
However, the effectiveness of MRgFUS neuromodulation is hindered by limitations in signal-to-noise ratio (SNR)
or image quality in MRI. The objective of this project is to develop an innovative RF coil array specifically
designed for MRgFUS neuromodulation applications. The proposed coil will overcome spatial constraints
imposed by the FUS device and water bath, improving SNR and enabling high-quality imaging of human brain,
especially deep brain structures such as the thalamus. Key innovations include the use of an imbalanced
current/capacitor distribution and irregular coil geometry to maintain high receive sensitivity, even when the coil
is displaced from the brain's center. These advancements will enhance the imaging quality of both structural and
functional MRI, ensuring more precise and effective therapeutic interventions. The project will involve advanced
electromagnetic simulations, the fabrication of coil prototypes, and performance testing. Successful
implementation of this novel RF coil array will significantly improve imaging quality in MRgFUS neuromodulation,
leading to better patient outcomes, improved patient comfort and expanded clinical applications of this non-
invasive treatment for neurological conditions.

Public health relevance
Project Narrative Magnetic Resonance-guided Focused Ultrasound (MRgFUS) neuromodulation is a non-invasive technique neuropathic pain by precisely stimulating brain regions with focused ultrasound, guided and monitored in real- time by MRI. However, there is currently no high-performance RF coil dedicated to this application due to spatial constraints imposed by the ultrasound device (transducers, water bath, and cables). This project aims to improve patient comfort, enhance imaging quality, increase therapeutic precision, and expand the clinical applications of MRgFUS neuromodulation through the development of an innovative RF coil array optimized for these specific challenges.